STEM Learning from Books Prior to Formal Education

Project Summary/Abstract
Promoting the development of STEM knowledge early in childhood helps to prepare children for success in
formal school entry, which, in turn, has cascading implications for future career success. Shared book reading
of STEM children’s books can be a simple and effective means for promoting STEM knowledge acquisition
early in development. However, there is currently limited understanding of whether and how shared book
reading promotes STEM knowledge acquisition prior to formal education. The current research investigates
STEM knowledge acquisition from shared book reading by examining both the quality of available STEM books
in children’s environments and how such books influence children’s learning in shared book reading contexts.
Specific Aim 1 identifies whether STEM children’s books provide supportive and demanding contexts for
acquiring STEM knowledge consistent with basic learning principles. Study 1 will be a textual analysis of
readily available children’s STEM books. The STEM books will be coded for whether they provide support for
encoding, through being cohesive and maintaining topics, and for the extent to which they are demanding of
children’s active processing by asking questions and including interactive prompts. Specific Aim 2 investigates
how support and demand for learning STEM facts present in children’s books and caregiver styles of reading
to their children interact to facilitate STEM learning. In Study 2, caregivers will read to their child published
STEM books that vary in their levels of support and demand. Then children will be tested on their recall of facts
learned in the books. This study will assess, in a naturalistic context, whether caregivers’ extra-textual talk is
affected by the books’ textual features to influence children’s recall of STEM facts. Study 3 uses experimental
control and manipulates how support and demand textual features influence STEM learning. Together, these
studies consider basic learning principles and take an ecologically valid approach to identifying how children
learn STEM information through contexts of shared book reading. This work will have broad implications for
promoting school-readiness and later academic achievement. Additionally, through this research, the fellow will
receive training in 7 areas. Specifically, the fellow will 1) acquire knowledge in a new STEM domain of STEM-
related semantic knowledge; 2) learn new coding techniques for the analysis of books and caregiver-child
interactions; 3) acquire more training in statistics and computer programming; 4) learn to translate research
findings to the public; 5) increase experience in mentoring students in research; 6) gain skills in teaching in a
domain related to research expertise; and 7) increase proficiency in writing grants. The fellow’s research
environment is ideal for supporting the research and training. The sponsor is an expert in semantic knowledge
and caregiver elaborative styles and has honors in mentoring and teaching; the collaborator has expertise in
textual analysis; the lab has excellent resources with a large participant pool, necessary space and equipment,
as well as a committed lab staff; and the department has excellent researchers in Cognition and Development.

Public health relevance
Project Narrative The proposed research will increase our understanding of how children acquire STEM knowledge early in development through the context of shared interactions during book reading. These findings will provide insight into the importance of reading high quality STEM books to children and will identify metrics that parents, teachers, and librarians can use in selecting STEM books. This work will have important implications for promoting children’s school readiness and later academic achievement on a large scale, reaching diverse populations across socioeconomic statuses.